Vet-Lirn Network Supplemental Capacity Building: 7500 FAST Real-Time System

Project Summary Abstract The Louisiana Animal Disease Diagnostic Laboratory (LADDL) is an accredited laboratory with the American Association of Veterinary Laboratory Diagnostician (AAVLD). We are committed to maintaining the highest accreditation standards, improving existing diagnostic services, and developing new tests to meet the demands of our industry stakeholders and regulatory agencies. LADDL works through cooperative agreements with the state and the USDA and its interagencies to perform diagnostic surveillance for endemic, targeted, and foreign animal diseases to enhance the biosecurity of the food and agricultural industries of the United States. LADDL is a member of the VeterinaryLaboratory Investigation and Response Network (Vet-LIRN), whose mission is to build a strong animal diagnostic network to provide sample analyses in the event of animal food or drug related illnesses or other large-scale animal/feed emergency events. LADDL is requesting supplemental capacity funding to purchase a 7500 Fast Real-Time qPCR Instrument to help promote and support the goals of the Vet-LIRN. This equipment will increase the capacity to identify agents involved in animal disease outbreaks and investigations.

Public health relevance
Project Narrative: Technical innovation has always been associated with better public health. Access to these innovations, new technologies and state-of-the-art equipment, is crucial for early detection and response to adulteration and contamination of animal food and drugs. Acquisition of new equipment for molecular diagnostic testing at the Louisiana Animal Diagnostic Laboratory and collaboration with the FDA's Veterinary Laboratory Investigation and Response Network (Vet-LIRN) will expand of our diagnostic capabilities and capacity for routine and emergency response, promoting human and animal health.